Small molecule Activators of the Faconi Anemia

C. Description of Core Unit This core (Core A) will provide small molecule and siRNA screening services, as well as mammalian cellbased assays, for the investigators in the three projects.